INTERACTION OF NONMUSCLE MYOSIN II WITH PLASMA MEMBRANES

In Drosophila, the gene product (Dlgl) of the tumor suppressor gene l(2)gl binds to nonmuscle myosin II (NMII) and the association is regulated by a kinase which binds to Dlgl (Kalmes et al., J. Cell Sci. 109, 1359, 1996). Mammalian cells contain a closely related protein which also binds a kinase regulating association with NMII. Since the kinase identity is unknown, we constructed a GST-fusion protein containing amino acids 617-731 of Mgl, the mouse homolog of Dlgl, to assist in purification of the kinase. The fusion protein contains 4 highly conserved serines, S650, 654, 658 and 662, which have been implicated as targets for the kinase. When GST-Mgl was incubated with PC12 lysates, precipitated with glutathione-agarose and subjected to in vitro kinase assay, the precipitates contained a tightly-bound kinase activity which phosphorylated GST-Mgl; mutation of the serine residues to alanine blocked phosphorylation. Taking advantage of the tight association of GST-Mgl and kinase, kinase activity was assayed in a pull-down assay using the fusion protein as affinity-ligand and substrate. Kinase activity was partially purified from a 25-60% ammonium sulfate fraction of rat brain high-speed supernatants. Sephacryl 300 chromatography was followed by ion exchange chromatography on Q-Sepharose, affinity chromatography on Blue Sepharose and gel filtration on Superose 6, leading to a 700-fold increase in specific activity. A major protein band of 80 kD in the extract binds to GST-Mgl and is phosphorylated on incubation with ATP; phosphorylation of both the fusion protein and the 80 kD band is inhibited by the protein kinase C (PKC) inhibitor GF109203X. Western blotting of proteins bound to GST-Mgl shows association of several PKC isoforms with the fusion protein. Future experiments will examine the binding of PKC isoforms to full-length Mgl and the phosphorylation of the full-length protein and its regulation in vitro and in vivo.